Developing data science solutions to mitigate the health impacts of heat in Africa: the HE2AT Center Project

Abstract: HE2AT Center Overall - Project summary/abstract Heat waves have major, though underappreciated, health implications, particularly for populations in low-income settings. The overarching objective of the Heat and Health African Transdisciplinary Center (HE2AT Center) is to develop innovative solutions to mitigate the health impacts of heat in Africa. The consortium of academic and non-academic partners is drawn from across sub-Saharan Africa and from the United States, and constitutes a multi-disciplinary group, including heat physiologists, biomedical and weather experts, public health practitioners, social-behavioral scientists as well as statisticians, and computer and data scientists. The Center will systematically develop a data ecosystem containing biomedical data, integrated with weather, air quality and other environmental data, and other geospatial data within two existing highly- complementary data platforms (IBM-PAIRS and the University of Cape Town). Over five years we will implement two Research Projects and 10-12 Pilot Projects, all streamlined and supported by the Administration, Data Management and Analysis, and Training and Engagement Cores. The first Project will implement an innovative data science approach to characterize the clinical outcomes of heat exposure in pregnant women and neonates. We will reuse data from cohorts and trials among pregnant women and neonates conducted across sub-Saharan Africa since the year 2000. Data from systematically identified studies will be integrated in an Individual Participant Data platform from data repositories and data owners. Then, analyses of relationships between heat exposure and outcomes (preterm birth, birth weight and pre- eclampsia) will inform quantification of heat-related disease burden. Finally, taking all findings together, we will pilot a district-level indicator, the first of its kind. The second Project assesses the burden of heat-related morbidity in urban settings using geospatial and heat hazard analyses in Abidjan, Cote d'Ivoire and Johannesburg, South Africa. This Project uses more complex data and data sources on the built environment and topography, for example, to assess heat-health impacts, and how these vary across urban geographies. Activities will inform development of an Early Warning System, including a digital App that delivers information to people on their forecasted risks of heat-health disease, based on their individualized risk profile, as determined by a machine learning algorithm which takes into account weather conditions, individual characteristics, geolocation and other factors that drive risk.
These systems are a central element in heatwave responses, allow for adequate preparations for heat events, which is especially important for population health and industry. We will collaborate closely with other Hubs and parts of the DS-I Africa consortium, supporting them to incorporate heat data within their research activities, and vice versa.

Public health relevance
The Heat and Health African Transdisciplinary Center (HE2AT Center) will generate knowledge on the impacts of heat waves and extreme heat, a leading weather-related cause of death in the United States, on clinical conditions and people in urban settings, applying data science approaches to existing environmental and health outcomes data from African populations already exposed to the extreme heat common in United States cities. The Center will develop and test innovative solutions for tracking heat-related conditions and for providing individualized early warnings of dangerous heat periods. Because these methods are reproducible and transferable, this knowledge can be applied across Africa and to help reduce heat-related risks in the United States, directly protecting American health by informing US heat warning systems, worker protection and clinical care.